Shared Resource: Microscopy, Imaging and Cytometry Resources

ABSTRACT The purpose of the Microscopy, Imaging and Cytometry Resources (MICR) Core is to enhance the peer reviewed funded research activities of KCI members whose research requires confocal microscopy, flow cytometry, small animal imaging and related techniques. To this end, during the current funding period the Core has facilitated 92 peer-reviewed publications by the cancer center members. The MICR Core is grouped in the Basic Research Core Cluster which, in addition to the MICR Core, includes the Proteomics and the Animal Model and Therapeutics Evaluation Cores. Capabilities and services include: confocal microscopy, multiphoton microscopy, conventional light microscopy, FRET and FRAP, TIRF and Atomic Force Microscopy, in vivo small animal imaging (including SPECT, CT, PET, x-ray, and optical imaging), flow cytometry and ratiometric analyses (e.g., intracellular pH and ion measurement studies), as well as three- and four- dimensional image reconstruction and quantitative measurements. MR imaging is also available through a collaborative effort between MICR and the MR Center. Our advanced imaging systems consist of a Zeiss LSM 410 confocal microscope equipped with six laser lines, a PerkinElmer UltraView ERS spinning disk confocal microscope equipped with three laser lines, a Zeiss LSM-510 META NLO confocal microscope with eight laser lines and multiphoton imaging, a Leica TCS-SP5 MP equipped with nine laser lines and multiphoton capability, a newly acquired Olympus/Bruker TIRF/AFM custom microscope and the cutting-edge Zeiss LSM 780 confocal microscope with six conventional laser lines and the InTune laser, a tunable white light laser with over 200 laser lines. Our flow cytometry systems include Becton Dickinson (BD) LSR II and BD FACSCanto II flow cytometers, a BD FACS Vantage SE SORP cell sorter and the newly acquired Amnis ImageStreamX Mark II imaging flow cytometer. The facility also provides conventional fluorescent microscopy through a Zeiss Axiophot Triple-Camera Photomicroscope, a Zeiss live cell imaging microscope with the state-of-the-art Apotome module capable of four dimensional imaging (3D in time). The in vivo small animal imaging unit is a newly upgraded combination of technologies made available to the core through the addition of Bruker In Vivo Extreme and MS FX Pro small animal optical/x-ray imagers, Siemens Inveon SPECT/CT and Concord MicroPET R4 small animal scanners. As mentioned above, small animal MRI is also available through collaborative efforts between MICR and the MR Center located next door. The analytical systems of the MICR Core include eight Apple and PC workstations with various analytical software and photographic quality printers and the MIP, Molecular Imaging Portal. MIP is a UNIX based central server with 45 TB storage capacity and a 74 TB robotic tape backup system as well as a dedicated applications server hosting the advance image analysis software, Matlab? and Definiens?, with two licenses each allowing up to two users access to each software simultaneously.

Public health relevance
Per guidelines, this section is left blank; not applicable to CCSG.